Mechanism of action and function of novel secosteroid 20(OH)D3 in the skin

Ultraviolet B both damages the skin and is required for photochemical transformation of 7-dehydrocholesterol
to vitamin D3 (D3). Sequential hydroxylation of D3 at C25 and C1α generates biologically active 1,25(OH)2D3
that displays a variety of pleiotropic activities. It was believed that all these effects are mediated by a single
molecule, 1,25(OH)2D3, and a single receptor, VDR. Discovery of alternative pathways, in which CYP11A1
oxidizes the side chain of D3 generating 20(OH)D3 that is further metabolized to other downstream
metabolites, (OH)nD3, challenged this dogma. 20(OH)D3, which is detectable in human epidermis at a
concentration higher than 25(OH)D3, and in human serum at ~3nM. 20(OH)D3, can act as an endogenous
regulator of epidermal barrier, while its presence in circulation indicates hormonal functions. 20(OH)D3 is
noncalcemic at pharmacological doses (30-60 µg/kg). Our ongoing studies have demonstrated that its
metabolites have anti-proliferative, pro-differentiation, anti-inflammatory, anti-oxidative, radioprotective, and
anti-cancer effects on skin cells both under in vitro and in vivo conditions, being even more potent than its
precursor. (OH)nD3 without OH at C1α are noncalcemic and non-toxic at supra-pharmacological doses.
Furthermore, they act on alternative nuclear receptors (NRs), such as agonists on aryl hydrocarbon receptor
(AhR) and liver X receptors (LXR)α and β, and as inverse agonists on RORα and γ. The latter is coupled to
their anti-inflammatory effects. The focus of this competitive renewal is on skin and photobiology. We will
determine the preclinical efficacy of selected (OH)nD3 metabolites, including 20,23(OH)2D3 and 20,25(OH)2D3
in comparison to their C1α(OH) derivatives, against UVB-induced damage and photocarcinogenesis, and
investigate the hypothesis that their protective and reparative functions are mediated through interactions with
distinct NRs. The hypothesis will be tested as follows: Aim 1. To define selected CYP11A1-derived (OH)nD3 as
efficient protective agents against UVB-induced skin pathology in vivo. Subaim 1: In vivo testing of preventive
and reparative properties of (OH)nD3. Their effects against UVB-induced epidermal damage will be tested in
SKH-1 mice and human skin ex vivo. Subaim 2: Testing selected (OH)nD3 against UVB-induced cancer in the
mouse models of photocarcinogenesis. The preventive or inhibitory activity of selected (OH)nD3 against UVB-
induced carcinogenesis will be tested in animal models to assess development and progression of SCC and
BCC. Aim 2. To define the mechanism of action (MOA) of selected (OH)nD3 compounds in protection against
UVB damage in the skin. First, we will evaluate the relative involvement of AhR and/or LXRs in comparison to
VDR in keratinocyte differentiation and photoprotection induced by (OH)nD3 compounds using skin from mice
in which the NR of interest is knocked out vs wild type mice. These studies will include transcriptomics,
proteomics, Chip-seq, and bioinformatics. The results will be validated in human skin cells with silenced genes
of interest vs controls. Alternative master regulators will also be considered, if experimentally indicated.

Public health relevance
During this renewal, using the best available in vivo models and state of the art methodology, we will define the protective role of novel CYP11A1-derived vitamin D3 hydroxymetabolites against UVB induced epidermal pathology including photocarcinogenesis. Through highly mechanistic studies we will define the nature of their anti-oxidative and DNA protective effects and mechanisms by which they regulate keratinocyte differentiation program with a focus on specific nuclear receptors (NRs). We will also investigate mechanistic links between the candidate NRs and downstream regulatory pathways.